Molecular pathobiology of soluble TREM2 in Alzheimer's disease

PROJECT SUMMARY
Alzheimer’s disease (AD) is the most prominent neurodegenerative disorder worldwide, and is pathologically
characterized by Aβ plaques and tau tangles. Growing evidence indicates that microglial receptors such as
TREM2 can play a role in both Aβ and tau pathology. TREM2 is proteolytically processed by ADAM proteases
to generate soluble TREM2 (sTREM2). Although sTREM2 levels are significantly elevated in cerebrospinal fluid
(CSF) along with tau and phospho-tau during early stages of AD onset, nothing was known with respect to
sTREM2 function prior to our previous R01 study. Our group and others established that TREM2 is a potential
Aβ receptor which mediates microglial activation in response to Aβ oligomers (Zhao et al., 2018). Moreover, our
prior mPI team showed that AAV-mediated sTREM2 expression could reduce Aβ accumulation and promote
microglial activation (Zhong et al., 2019). Interestingly, the TREM2 cleavage site was recently shown to occur at
H157, where an AD-associated H157Y TREM2 variant enhanced TREM2 ADAM-dependent TREM2 cleavage.
We therefore integrated the H157Y mutation into the murine Trem2 locus, and characterized effects of H157Y
Trem2 in a 5xFAD background. We found that similar to sTREM2 expression, H157Y Trem2 reduced Aβ plaque
load and enhanced Aβ clearance, suggesting that enhanced sTREM2 associated with H157Y Trem2 can reduce
Aβ. Unexpectedly, we also observed that unlike sTREM2, H157Y Trem2 suppressed microglial activation
signatures (manuscript in revision), suggesting that in addition to potential sTREM2-dependent effects
associated with enhanced sTREM2 shedding, H157Y Trem2 may also be associated with potential loss-of-
function phenotypes linked to elevated TREM2 cleavage and inactivation.
A key question remains how H157Y Trem2 can enhance Aβ clearance, and is yet associated with elevated
AD risk. Our results indicate that Trem2 deletion can aggravate tau dispersion and pathogenesis through
enhancing distribution of seed-competent tau in microglial exosomes (Zhu et al., 2022). Our preliminary results
also indicate that sTREM2 enhances internalization of tau oligomers in microglia, and promotes trafficking of
internalized tau to pre-exosomal compartments, which suggests that although H157Y Trem2 confers
neuroprotective effects with respect to Aβ clearance, H157Y Trem2 could potentially aggravate tau pathology
through combined gain-of-function (sTREM2) and loss-of-function (TREM2 cleavage/inactivation) effects. To
decipher gain and loss-of-function effects associated with H157Y Trem2 with respect to Aβ and tau, we propose
to use a combination of mouse AD (5xFAD, PS19; AAV-tau dispersion models) and human cell models (ESC-
derived microglia models) to distinguish between effects of Trem2 KO, H157Y and sTREM2 on Aβ and tau
pathology and microglial activation states, as well as distinguish effects of H157Y TREM2 in mouse and human
microglia using ESC-derived xenotransplantation models in hMCSF/5xFAD mouse brain. This will allow us to
decipher sTREM2-dependent and independent effects associated with H157Y TREM2 in AD pathology.

Public health relevance
PROJECT NARRATIVE TREM2 is a genetic risk factor for Alzheimer’s disease (AD), where an AD-associated H157Y TREM2 variant has been recently shown to enhance cleavage and shedding of a soluble TREM2 (sTREM2) form. The purpose of this competitive R01 renewal is to characterize sTREM2-dependent and independent effects on Aβ and tau pathology and microglial activation states using a combination of mouse and human microglial models. Results from this work can define how this unique TREM2 variant can alter microglial behavior with respect to Aβ and tau, and provide insight into differences in H157Y TREM2 in murine and xenotransplanted human microglia in a mouse AD model.